Structure, function, and evolution of gene regulatory networks in archaea

The broad goal of the Schmid lab is to understand how stress response mechanisms evolved. Archaea
are the evolutionary progenitors of eukaryotes according to mounting phylogenomic evidence. Transcriptional
regulation is required across life for surveillance and immediate response to stressful conditions. Transcription
proteins, including transcription initiation proteins TATA binding protein (TBP) and Transcription Factor B (TFB),
and histones, are strongly conserved across eukaryotes and archaea; however, it remains unclear in both
domains of life how these proteins function together with other transcription factors (TFs) in transcription
regulatory networks (TRNs) to sense and respond to stress. Moreover, how TRNs evolve under selective
pressure from abiotic stress remains a major knowledge gap. Archaea dominate in stressful environments, where
conditions vary between extremes of temperature, pH, and salinity. They are single-celled microorganisms that
lack nuclei and complex posttranscriptional mechanisms. Together these features present an ideal, simplified
model for understanding conserved mechanisms of transcriptional regulation in response to stress, and how
those mechanisms evolve. Recent research in the Schmid lab discovered specific examples of TRN conservation
and rewiring by comparing the architecture and dynamic function of TRNs across related species of hypersaline
adapted archaea, or haloarchaea. Together, this research has led us to hypothesize that extreme and variable
abiotic stress conditions select for more highly interconnected or complex TRNs, enabling rapid
physiological adjustment in response to variable environments. To test this hypothesis, here we will use an
integrated experimental and computational systems biology approach pioneered in the Schmid lab to
characterize TRN architecture (how TFs interact with their target genes) and function (dynamical gene
expression and phenotypic outcomes) across the entire archaeal tree. We will compare these TRNs with those
in eukaryotes to determine how TFB/TBP function is conserved, and to detect patterns of TRN conservation vs
rewiring across large evolutionary distances. We expect that the research results will yield fundamental insight
into transcription mechanisms across domains of life.

Public health relevance
The goal of the proposed research is to test the hypothesis that abiotic stress conditions select for more highly interconnected or complex transcription regulatory networks, enabling rapid physiological adjustment in response to variable environments. We will test this hypothesis in archaea, the evolutionary progenitors of eukaryotes. This research has the potential to create breakthroughs in understanding how transcriptional mechanisms of stress response are conserved across the tree of life.